Defining the Role of TCF21 in Adventitial Fibroblasts in Atherosclerosis

PROJECT SUMMARY
Coronary artery disease (CAD) remains a rising cause of morbidity and mortality in the United States. Human
genetics suggest that a significant portion of the inheritable risk of CAD is related to fibroblast-specific regions of
the genome. Using single cell transcriptomics, our group has identified a transcriptionally distinct adventitial
fibroblast (AdvFib) population, which undergoes early phenotypic modulation during atherosclerosis
development. Specific ablation of AdvFib significantly reduces plaque burden, suggesting their ability to influence
atherosclerosis. To identify regulators of AdvFib, we characterized regions of altered chromatin accessibility upon
AdvFib activation, revealing the transcription factor Tcf21. Tcf21 is predominantly expressed in AdvFib, and its
expression declines upon AdvFib phenotypic activation. Tcf21 knockout in murine AdvFib increases vascular
calcifications and upregulation of pro-atherogenic inflammatory cytokines.
Given the restricted expression of Tcf21 to AdvFib and phenotypic activation of AdvFib upon Tcf21 knockdown,
the central hypothesis underlying this proposal is that overexpression of Tcf21 locks AdvFib in a quiescent state,
which then prevents the downstream activation of non-cell-autonomous signals that trigger plaque formation.
Using an AdvFib-specific Tcf21 overexpression mouse model, I will characterize histological changes in plaque
and alterations in non-AdvFib plaque cells, such as smooth muscle cells and inflammatory cells. I will then use
single-cell RNA sequencing to characterize transcriptional changes of AdvFib upon Tcf21 overexpression and
downstream transcriptional changes in non-AdvFib plaque cells.
Given the putative effect of Tcf21 on the activation/recruitment of inflammatory cells, my goal is to characterize
the precise epigenetic regions of Tcf21 binding to understand how Tcf21 regulates inflammatory cytokine
production. Overall, this study will elucidate the role of AdvFib in atherosclerosis and characterize how Tcf21
regulates AdvFib.

Public health relevance
PROJECT NARRATIVE Adventitial fibroblasts are a population of cells that undergo marked changes in behavior upon the development of coronary artery disease. TCF21 is a transcription factor associated with coronary artery disease, and we suspect that TCF21 controls adventitial fibroblasts to protect against atherosclerosis. To investigate this, we will significantly increase the level of TCF21 in adventitial fibroblasts and examine how this changes the degree of atherosclerosis, and utilize genetic tools to understand how higher levels of TCF21 affect adventitial fibroblasts as well as other cells that contribute to plaque.